The mutagenic consequences of replication-coupled DNA repair mechanisms

Project Summary
Environmental genotoxins such as oxidation agents, alkylating agents, aromatic amines, crosslinking agents,
polycyclic aromatic hydrocarbons, and natural toxins induce a full spectrum of DNA lesions including abasic
sites, interstrand crosslinks, and bulky DNA base adducts. These environmental genotoxins are found in our
waterways, food, industrial and agricultural chemicals, and air pollution and have the potential to induce
mutagenesis and genomic instability if genetic lesions are not repaired. Mutagenesis and genomic instability can
lead to developmental disorders, aging, and cancers. HMCES is a replication-coupled repair protein that
responds to single-strand DNA abasic sites and prevents their cleavage by AP-endonucleases. Abasic sites are
a common lesion caused by environmental genotoxins. My preliminary results suggest that HMCES prevents
both genomic instability and mutagenesis, and I hypothesize that it promotes a more faithful repair mechanism
such as template switching or fork reversal. For the K99-phase of this proposal I will learn to perform short and
long-term mutagenesis assays and DNA deep sequencing methods to understand in detail how HMCES
prevents mutagenesis and genomic instability in human cells and promotes more error-free repair. This work will
create a technical foundation and blueprint for studies (R00) characterizing the strand-specific replication stress
response and how strand-specific obstacles and environmental genotoxins contribute to leading and lagging
strand mutagenesis. There are core differences between replication on the leading and lagging strands. DNA
replication occurs continuously on the leading strand and discontinuously on the lagging strand through a series
of repriming events. I hypothesize that strand-specific lesions and obstacles generate a differential replication
stress response, and potentiate mutagenesis differently. I will characterize the lagging and leading strand stress
responses using unbiased approaches. Further, I will determine the consequences of strand-specific stress and
genotoxins on mutagenic strand bias using deep sequencing-based mutagenesis assays. Ultimately, this
proposal will advance the environmental toxicology and DNA repair fields leading to paradigm shifting
discoveries.

Public health relevance
Project Narrative The replication stress response is required to repair DNA lesions that arise due to both endogenous sources and environmental genotoxins found in water, food, and industrial chemicals. This proposal aims to discover how the replication-coupled protein HMCES protects cells from genomic instability and mutation (K99) and more broadly how DNA-strand specific obstacles contribute to mutagenesis (R00). Completing this proposal will characterize how cells prevent mutagenesis in a new context uncovering mechanisms in DNA repair.